Advances in Skeletal Muscle Growth, Repair and Disease

SUMMARY
The biannual Frontiers in Myogenesis conference has distinguished itself as a forum for the exchange of
cutting-edge ideas on the development, physiology, and pathology of skeletal muscles. The conference brings
together leading scientists from around the world to promote new research directions and novel therapeutic
approaches, as well as to foster highly productive collaborations with leading scientists in the field. In keeping
with the Frontiers ideals of exploring new territory and creating new opportunities at the edge, we are for the first
time bringing the conference to South America, to the Sophitel Guaruja Jequitimar Hotel, in São Paulo, Brazil,
from November 6-10, 2023. We expect to draw significant participation from South America, especially the local
area which includes 5 major research universities. The theme of the 2023 conference is “Advances in Skeletal
Muscle Growth, Repair and Disease” and the major goal of the conference is to disseminate exciting mechanistic
advances in our understanding of processes that regulate myogenesis, developing novel strategies for studying
and treating muscle diseases, such as the generation of muscle stem cells from induced pluripotent stem cells,
and bioengineering approaches for skeletal muscle modeling, and advances in our understanding of intrinsic
and extrinsic changes responsible for muscle impairment with aging and approaches to address these
therapeutically. The conference will also address mechanisms of human skeletal muscle disease as well as
novel therapeutics, focusing on both genetic diseases of muscle such as Duchenne Muscular Dystrophy and
Facioscapulohumeral Muscular Dystrophy as well as acquired pathologies, such as aging. These topics will be
presented over 11 sessions by 55 speakers. Importantly, the conference will promote interaction and mentoring
between junior and established investigators through poster sessions including poster blitz 1 min oral summaries
of selected posters, short talks for junior investigators, and lunch sessions at which participants may sign up to
join tables of specific speakers. The conference will also include three professional development sessions
providing guidance on the grant application process, how to promote diversity and inclusion in science, and a
meet the editors session on guidance in the area of publishing in high visibility journals. We will provide an
informal, friendly, inclusive and constructive environment for all participants, ensuring participation of women,
under-represented minorities and individuals coming from disadvantaged backgrounds.

Public health relevance
NARRATIVE The 2023 Frontiers in Myogenesis Meeting “Advances in Skeletal Muscle Growth, Repair and Disease” will provide a forum for international leaders in muscle research to present major new discoveries in skeletal muscle development, regeneration, aging and disease. The speakers represent an outstanding group of investigators from around the world, at all career stages; furthermore over a third of the slots are dedicated to short talks selected from the abstracts, ensuring representation of exciting new developments and providing additional opportunities for young investigators to present their work to the muscle community. The 2023 conference brings the Frontiers meeting to South America for the first time, therefore will foster cross-fertilization not only between diverse areas of research, but also between scientists of the global north and the global south, to advance our understanding of muscle biology, and to facilitate the development of therapeutic approaches for muscle diseases.